Continuous non-invasive assessment of blood pressure profile in persons with Alzheimer's and its related dementias

Abstract: The current standard-of-care for measurement of BP monitoring is the periodic use of occlusive arm-
cuff devices. However, its utility is compromised by two critical limitations to measuring an individual’s true BP:
1) overall measurement inaccuracy and 2) inability to measure BP continuously. These limitations underscore a
critical unmet need for accurate, continuous, non-invasive blood pressure (cNIBP) monitoring that can be used
for management of hypertension (HTN) and other chronic diseases. To address this need, we have developed
ViTrack™, a cuffless, wrist-wearable device that uses a fundamentally new method to accurately and non-
invasively measure BP continuously. ViTrack’s beat-to-beat continuous measurements accurately provides
patient’s true BP, including daytime and nighttime BP, circadian BP patterns, and BP variability (BPV). ViTrack
also measures heart rate, respiratory rate, and wrist actigraphy to assess activity/sleep patterns. In Direct-to-
Phase-II study [Grant#:1R44 HL158374-01] we are assessing BP parameters in a wide range of patients.
ViTrack will address the need for accurate and continuous BP monitoring to prevent disabilities in
persons with Alzheimer’s disease and its related dementias: HTN is the most common co-morbidity in
persons with Alzheimer’s disease and its related dementias [1]. Effective HTN therapy offers the chance to
reducing disability from cardiovascular or cerebrovascular events [2]. However, optimal management of HTN in
people with dementia is hampered by the current dependence on periodic blood BP monitoring using occlusive
arm-cuff devices [2]. Persons with dementia often have sleep disturbances and behavioral issues, in addition to
autonomic dysfunction, which can significantly affect BP hemodynamics. These are almost never detected by
random solitary measurements in the clinical setting [3,4,5]. Adding another challenge, dementia patients with
poorer cognitive ability and behavioral issues do not tolerate frequent BP measurements [6]. HTN drug treatment
tailored to circadian BP profile is critical to avoid orthostatic hypotension and/or hypotension, which can lead to
weakness, contribute to falls and further cognitive decline [7,8,9,10]. Furthermore, the co-occurrence of
behavioral events and BP changes in people with dementia is well recognized and perhaps modifications in BP
could prevent or temper their agitation or aggression [11]. Thus, the development of rational therapeutic
strategies to modulate BP and reduce disability in those with Alzheimer’s disease and its related dementias is
dependent upon accurately assessing and characterizing their BP profile. ViTrack enables nonintrusive gathering
of a patient’s beat-to-beat 24-h BP profile, both accurately and reliably, for the first time.
ViTrack can address the need for accurate, continuous, and ubiquitous BP measurements for
Alzheimer’s disease and vascular cognitive impairment–dementia prevention: Almost 40% of the US adult
population has HTN [12]. Evidence suggests that midlife HTN contributes significantly to the development and
progression of both Alzheimer’s disease and vascular cognitive impairment–dementia [13,14,15,16,17,18]. The
Systolic Blood Pressure Intervention Trial (SPRINT)-MIND, demonstrated that intensive BP control (SBP <120)
was associated with a significant reduction in the rate of minimal cognitive impairment and trended toward
reducing the rate of dementia development compared to standard BP control (SBP 135-140) [19]. While SPRINT-
MIND has reemphasized the broader public health benefits of BP lowering, confidence in the data is diminished
by use of periodic clinic BP measurements [20]. These same impediments compromise population-level
lifecourse interventions for BP control and dementia prevention [21,22,23,24]. Random cuff measurements lead
to a 30% error rate in HTN diagnosis [25,26] and are not optimal for HTN management. Hence, < 50% of patients
with HTN are poorly controlled [27,28]. Increased BPV and nighttime BP abnormalities are independent risk
factors for dementia [29,30,31,32,33,34]. Recent systematic review and meta-analysis shows the relative
contribution of BPV to the risk of dementia and cognitive impairment exceeded that of mean BP [35]. But
accurate assessments of BPV and nocturnal BP are among the most difficult to obtain using periodic, cuff-based
BP methods [36]. ViTrack can provide accurate measure of 24-hr mean BP, nighttime BP profile and BPV to
reliably evaluate risk and control BP to protect brain health and prevent or slow the progression of dementia in
later age.
In this Supplemental grant, we propose to expand our ongoing clinical study to collect beat-to-beat 24-hour BP
with ViTrack in age-matched subjects with and without Alzheimer’s disease and its related dementias (N=25 per
group; total = 50). The study is adequately powered to compare BP profile (24-h mean SBP and DBP; daytime
and nighttime mean SBP and DBP; BPV) between the groups. This pilot data can be used to design more
extensive longitudinal trials that will define the potential hemodynamic benefits of therapeutic interventions in
these groups, as a strategy to prevent additional disabilities in persons with dementia. The proposed pilot study
will also further validate ViTrack’s promise as an individual and population level tool, as part of a lifecourse
strategy, to assess and control BP in order to protect brain health and mitigate the risk of age-related dementia.

Public health relevance
Project Narrative Hypertension is the most common co-morbidity in persons with Alzheimer’s disease and its related dementias. The extent and frequency of blood pressure assessment in this population is limited. For the first time, this study will provide beat-to-beat blood pressure and other hemodynamic profile data in a limited number of dementia patients.